LEUCINE DISPOSAL RATE, OXIDATION RATE, AND SYNTHETIC RATE IN NEWBORN INFANTS

We propose to study the rates of leucine disposal, oxidation and incorporation into protein in newborn infants who have established an appropriate milk intake and are clinically stable.